RAPID ELECTROCHEMICAL BIOSENSOR FOR POINT-OF-CARE DIAGNOSIS OF JOINT INFECTION

Periprosthetic joint infection (PJI) is a devastating complication following total joint replacement (TJR) often with
major long-term consequences and morbidity. As many as 100,000 orthopedic infections are diagnosed each
year in the US, a number that is expected to rise exponentially. However, the scope of the problem is much
larger. Persistent pain is reported in up to 80% of patients after joint surgery, and all painful orthopedic implants
require a complete evaluation to rule out the possibility of PJI. Concern for infection is also the single most
common reason for patients to present to the emergency department after TJR. Unfortunately, making the
diagnosis of infection remains a major challenge, especially since outward clinical signs, such as erythema and
swelling, are not specific to PJI. Immediate and accurate diagnoses that also avoid unnecessary overtreatment
are critical for favorable outcomes, especially given that PJI management often requires multiple operations and
prolonged hospitalization. Nevertheless, underlying infections still commonly go undetected due the nature of
existing diagnostics, which are outdated, slow, and imprecise. Problems include the inability to isolate infectious
organism(s) in 20-50% of cases (‘culture-negative’), long incubation times required to isolate certain pathogens,
and the relatively high incidence of false positives. Alternative diagnostic tools are also limited – either synovial
fluid must be transported to a central laboratory for testing or outdated point-of-care (POC) diagnostic technology
must still be employed that yields less accurate, binary results (‘infected’ or not). So how should physicians make
timely and accurate diagnoses? Our team was the first to discover the diagnostic value of synovial fluid leukocyte
esterase (LE), an antimicrobial protease released by activated neutrophils recruited to sites of bacterial infection.
Since that discovery, the original LE ‘dipstick’ test (Roche Chemstrip®) has been used by physician to aid in PJI
diagnosis with a high diagnostic accuracy of about 89% and a negative predictive value as high as 97%.
Nevertheless, the test in its original form designed for urinalysis is impractical for widespread use in orthopedics.
The ‘dipstick’ is a dry chemical reagent pad, in which a surface reagent reacts with esterase in the sample to
produce a purple dye. The result is read by a clinician based on the degree of color change on the test pad.
Unfortunately, lack of objectivity severely limits its clinical reliability. Joint fluid samples must also be centrifuged
in an attempt to remove blood and debris that can distort results. Our breakthrough LE test is a POC diagnostic
assay that provides a rapid quantitative LE measurement with just a tiny droplet of synovial fluid. Results are
immediately available to providers via a mobile app in just 2 minutes to drive clinical decisions. In Phase I, we
overcame significant challenges and delivered a highly stable production-ready prototype without signal drift or
matrix interference, and designed a low-cost analyzer. Our Phase II goals are to prepare for scale manufacturing
of production LE sensors and analyzers, perform master validation to establish product claims for FDA clearance,
and conduct a multi-center study to determine real-world diagnostic accuracy of the device in the field.

Public health relevance
Infection is a devastating complication following hip or knee joint replacement, with major long-term consequences for patients and an immense societal burden. Making a prompt diagnosis is challenging with current standard of care diagnostic tests, often leading to delays in diagnosis that can exacerbate the morbidity of the condition. Our team is developing a breakthrough point-of-care biosensor to diagnose joint infection with results available immediately for physicians in just 2 minutes to guide timely clinical decisions and improve the chances for a successful outcome.